Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The primary objective of this Core Center for Clinical Research is to promote impactful research
in pediatric rheumatic and non-inflammatory musculoskeletal diseases (PMSKD) by the local and
national Research Community with a focus on enhancing our well-established research programs
and institutional expertise in juvenile idiopathic arthritis (JIA), childhood-onset systemic lupus
erythematosus (cSLE) and juvenile-onset fibromyalgia (JFM). The role of the Administrative
Core (AC) is to serve as the executive, coordinating and oversight component of the Pediatric
musculOskeletal & RheumaTology Innovation COre center (PORTICO) to enhance clinical
research in PMSKD. The proposed Director is Hermine I Brunner, MD MSc MBA, and the
Associate Director is Susmita Kashikar-Zuck, PhD, both well-established and senior clinical
researchers. The chief executive & administrative body of PORTICO will be a 7-member
Executive Committee (EC) composed of Drs. Brunner and Kashikar-Zuck and 5 highly
accomplished scientists who will serve as the Director and Associate Director/s of the
Methodology Core & Patient Assessment Resource Core. The EC will be supported by an Internal
Advisory Committee, External Advisory Committee and Pilot and Feasibility study committee. The
specific aims of the AC are (1) Provision of executive and scientific leadership for the efficient
conduct and dissemination of innovative team science in PMSKD, (2) Development of an
Outreach Program to promote interdisciplinary clinical research in PMSKD locally and nationally
and (3) Provision of opportunities to test new ideas by creating and managing a Pilot & Feasibility
Studies Program to fortify the goals of PORTICO. The AC will be responsible for focusing
PORTICOs services, innovation and educational offerings to be complementary to those that
already exist within the rich research environment within Cincinnati Children's Hospital and the
University of Cincinnati College of Medicine and national resources and research networks to
which the AC leadership is well connected. For the AC, we have developed a robust leadership
plan, along with plans for communication, management and evaluation of the activities and
resources of PORTICO. In addition, the AC will manage the outreach program, work to enhance
the research community to support novel and innovative work by established and early career
investigators to advance the field of PMSKD research.